Shared Resource 15: Recruitment, Intervention, and Survey (RISSR)

PROJECT SUMMARY – RECRUITMENT, INTERVENTION AND SURVEY SHARED RESOURCE (RISSR)
The RISSR was established in 2003, as the Behavioral Measurement Shared Resource (BMSR), to provide a
mechanism for supporting behavioral, epidemiological and clinical research within the broader research goals of
the OSUCCC. Renamed in 2019, the RISSR provides essential services to support non-interventional studies
(observational, epidemiologic) as well as non-therapeutic intervention studies. Thus, the RISSR is a niche
service for population scientists in CC and MCC providing efficient and high quality services for investigators to
conduct population science research. RISSR also works with the BSSR to support the Total Cancer Care (TCC)
project accruals, and translational research involving human data collection and interventions for all 5 research
programs. For the next funding period, the RISSR specific aims are to: 1) provide expertise in research design,
the selection and/or development of surveys and study measures, including patient-reported outcomes; 2) assist
investigators with participant recruitment, accrual goals, and retention to ensure the inclusion of research
participants that are representative of the target population(s); and 3) provide investigators with expertise and
services in the collection and management of quantitative and qualitative research data, and population-based
data retrieval for grant applications and registry studies. Collected data are managed for seamless transfer to
the BSR for data analysis. Over the current funding cycle, the major changes to the RISSR were greater adoption
of electronic data collection for the majority of OSUCCC studies, using text messaging with participants for more
flexible communication, data collection and study conduct; increased use of mobile health interventions; and
providing support for more program projects and large multi-heath center/ multi-state research projects. During
the current funding cycle, RISSR has supported 35 principal investigators (54% OSUCCC members) and
contributed to 71 publications (1 >10 impact factor) and 9 NCI grants including 1 K01, 1 K07, 1 K12, 1
P01, 2 P50s, 2 R01s, and 1 R37. The RISSR will directly support the OSUCCC priority for immune-oncology
and cancer prevention and control. The RISSR will expand its staff, instrumentation and services before capacity
is reached. In the next funding cycle, the RISSR will: 1) further develop and customize survey and data collection
methods; 2) expand and support participant recruitment registries for rapid accrual for interventional and
epidemiological studies; 3) expand the provision of smart phones to study participants to reduce disparities in
participant recruitment and participation; and 4) develop greater linkages with the BISR to share computer
platforms and expertise related to clinical informatics, eHealth interventions using the electronic health record,
and health services research. The RISSR will also work with the BSR and BISR as part of the Biomedical
Informatics Coordinating Center (BMICC) Working Group to establish national data coordinating centers at the
OSUCCC on cancer-related topics. The annual budget of the RISSR is $1,631,722, yet the CCSG request is
$92,102 (5.6%) reflecting strong institutional support and a robust chargeback system.